Gender-Affirming Testosterone Therapy on Breast Cancer Risk and Treatment Outcomes

This proposal will undertake preclinical studies to address breast cancer (BC) risk and treatment concerns of
transmasculine people (female-to-male transition). This proposal will also elucidate the interplay of miRNAs
and testosterone in mammary gland development, carcinogenesis, and response to BC treatment. Most
transmasculine individuals pursue testosterone therapy (TT) to treat their gender dysphoria. The breast is a
sex hormone-sensitive organ. Transmasculine individuals who receive TT are now a subject of concern – very
little is known about how such high levels of testosterone affect the breast and subsequently risk of developing
BC. Prospective human studies will take decades. Mouse aging is accelerated by a factor of 70 compared to
humans, and the hormone regulation of breast development is similar in mice and humans. Aim 1 will use two
mouse models to clarify the extent to which TT affects the risk of developing estrogen receptor positive (ER+)
and negative (ER-) BC. We will compare the incidences and tumor specific survival in female mice (intact) and
oophorectomized female mice receiving TT with their respective counterparts that do not receive TT (Aim 1.1).
On the other end of the spectrum, for transmasculine patients diagnosed with BC, there are neither clinical
guidelines nor risk-benefit studies on whether they can continue TT while being treated for BC. There is a gap in
knowledge about whether testosterone affects the efficacy of BC treatment. The discontinuation of TT is
undesirable as it affects these patients’ emotional wellbeing and body image, and compounds their cancer-
induced emotional distress. Aim 2 will address the clinical treatment issue of whether continuing testosterone
affects BC treatment outcomes. Aim 2 will use the same two mouse models to investigate whether continuing
testosterone affects alpelisib (FDA approved therapy for ER+ tumors harboring a PIK3CA mutation) or olaparib
(FDA approved therapy for ER- tumors harboring a BRCA1 mutation) treatment outcomes (Aim 2.1). We will
leverage Aims 1.1 and 2.1 to conduct molecular investigations about the effect of TT on androgen receptor and
ER mediated transcriptional programs—mRNA and miRNA expression—on regulating mammary gland
development and carcinogenesis (Aim 1.2), and response to BC treatment (Aim 2.2). Transgender people are
the fastest growing group in the LGBTQ community. We need to start understanding their cancer risk and the
long-term health outcomes of TT. Our proposal will be the first to lead to fundamentally new insights to
understand BC risk and develop clincial treatment guidelines to improve BC outcome in the medically
underserved transmasculine population. The increased understanding of the role of sex hormones in BC risk
and treatment, as well as the miRNA landscape in regulating androgen expression in BC, are not only
important to improve transmasculine health and reduce their healthcare disparities. These knowledge will have
direct implications for understanding BC risk and open up new avenues of treatment for cisgender men and
women as well.

Public health relevance
Project Narrative There is a lack of knowledge about the effect of gender-affirming hormone therapy on cancer risk and cancer treatment. We will utilize mouse models to understand the extent to which testosterone therapy affects breast cancer development (Aim 1) and breast cancer treatment outcome (Aim 2). Our proposal will gain new insights about breast cancer risk as well as develop new approaches to improve cancer outcome in both the underserved transmasculine community and the cisgender population.